Developing Pluripotent Stem Cells to Model and Treat Lung Disease

SUMMARY: OVERALL PROGRAM
The goal of this Program Project Grant (PPG) is advancing the latest discoveries in stem cell biology, human
organoid models, and gene editing to understand and treat genetic lung diseases. After a century of basic
sciences advances, culminating in recent Nobel Prize-winning discoveries, such as nuclear reprogramming
and gene editing, biomedical research now faces an inflection point, poised for clinical translation of basic
science successes. While it is hard to envision a more optimistic time in health-related research, treatments for
many devastating lung diseases have not yet been realized, and clinical therapies in most cases still largely
focus on treating symptoms or maintaining life support to allow endogenous lung tissue stem cells enough time
to repair, without available therapies able to interrupt disease-initiating mechanisms or augment the lung’s
capacity to regenerate. Here we address these challenges by proposing an integrated, multi-investigator PPG
to translate lung stem cell research from basic discovery to future clinical applications. An initial focus on
ameliorating genetic lung diseases of the airway and alveoli is pursued, given that their proximal
disease-driving gene mutations are well described. The use induced pluripotent stem cells (iPSCs) carrying
these mutations or their gene-edited progeny is a shared technology harnessed by all Projects together with a
proposed Gene Editing Core, and coordinated by an Administrative Core. Our 4 project leaders have worked
together extensively to develop protocols to differentiate iPSCs into a broad diversity of lung epithelial lineages,
recently optimizing methods to produce the two stem cell populations that maintain all airway and alveolar
epithelia, basal cells and alveolar type 2 cells (AT2s), respectively. Having established these stem cell banks
and protocols, we turn our focus here on applying these resources to advance our mechanistic understanding
of how gene mutations initiate airway and alveolar epithelial dysfunction resulting in disease, and we seek to
therapeutically intervene with novel precision therapeutics or regenerative cell therapies. Towards these
goals, we here propose 4 projects and 2 cores, all interacting to complete shared aims, and synergistic
cross-project experiments. Aim 1 will promote collaborative, integrated cross-project approaches that
produce new human models of genetic airway and alveolar diseases, and will apply these in vitro iPSC and
organoid-based models to understand basic pathogenic mechanisms that lead from epithelial dysfunction to
lung disease. Aim 2 will identify potential therapeutic strategies able to reverse or ameliorate aberrant
pathways responsible for the alveolar dysfunction present in genetic diseases that affect the distal lung,
including proteostasis, mitochondrial dysfunction, and metabolic changes that we hypothesize lead to
reversible epithelial toxic gain-of-function phenotypes. Aim 3 will develop a future approach for treating genetic
lung diseases based on the in vivo reconstitution of airway and alveolar stem cell compartments via
intra-airway transplantation of pluripotent stem cell-derived airway basal or distal alveolar epithelial cells.

Public health relevance
PROJECT NARRATIVE Lung diseases, such as those caused by gene mutations, result in significant morbidity and mortality worldwide. The advent of stem cell discoveries and regenerative medicine presents new opportunities to improve our understanding of these diseases and to develop new treatment approaches. Here we propose a Program Project Grant, composed of 4 integrated projects and 2 cores, whose goal is advancing the latest discoveries in stem cell biology, human organoid culture models, and gene editing to better understand and develop new treatments for genetic lung diseases.